Translational Control of Morphology and Virulence in Candida albicans

PROJECT SUMMARY/ABSTRACT
Candida albicans, the most commonly isolated human fungal pathogen, is responsible for a wide variety of
systemic and mucosal infections. Immunocompromised individuals, including cancer patients on
chemotherapy, AIDS patients, neonates, and organ transplant recipients, are particularly susceptible to
infection. The ability of C. albicans to undergo a reversible morphological transition from single budding yeast
cells to filaments (elongated cells attached end-to-end) is important for virulence as well as several virulence-
related properties. While transcriptional and post-translational mechanisms that control the C. albicans
morphological transition have been well-characterized, considerably less is known about the role of
translational mechanisms. We have recently discovered that UME6, which encodes a key filament-specific
transcriptional regulator of C. albicans morphology and virulence, possesses one of the longest 5’
untranslated regions (UTRs) identified in fungi to date. The UME6 5’ UTR inhibits C. albicans filamentation
under a variety of inducing conditions as well as the ability of UME6 expression to determine C. albicans
morphology. The 5’ UTR does not affect UME6 transcript levels or induction kinetics, but instead specifically
reduces translational efficiency of UME6, as determined by a polysome profiling analysis. Importantly, the
level of translational inhibition directed by the UME6 5’ UTR is modulated by different filament-inducing
conditions. A recent preliminary ribosome profiling experiment indicates the presence of two distinct ribosome
stalling sites in the UME6 5’ UTR, both of which are located immediately upstream of predicted complex
stable RNA secondary structures. An RNA-seq analysis has demonstrated that in addition to UME6, a
significant number of C. albicans genes involved in filamentation, and a variety of other virulence-related
processes, including biofilm formation, adhesion, and secreted degradative enzyme production, also possess
long 5’ UTRs. Based on this evidence, our hypothesis is that 5’ UTR-mediated translational efficiency
mechanisms play an important role in controlling C. albicans morphology, virulence and virulence-related
processes in response to host environmental cues. In order to address this hypothesis, we plan to: 1)
determine how C. albicans filamentous growth signaling pathways control morphology and Ume6 expression
by regulating UME6 translational efficiency via the 5’ UTR, 2) determine the molecular mechanism(s) by
which the UME6 5’ UTR inhibits translational efficiency, 3) determine the broader role of 5’ UTR-mediated
translational efficiency mechanisms in controlling C. albicans virulence and a variety of virulence-related
properties. These studies will provide a better understanding of how 5’ UTR-mediated translational efficiency
mechanisms control morphology and virulence in a major human fungal pathogen. Ultimately, common
fungal-specific components of translational efficiency mechanisms that regulate fungal pathogenicity could
serve as potential targets for the development of novel and more effective antifungal strategies.

Public health relevance
PROJECT NARRATIVE Relevance to public health: Candida albicans, a major human fungal pathogen responsible for life- threatening yeast infections in a wide variety of immunocompromised individuals, possesses the ability to undergo a reversible morphological transition from yeast to filaments. This proposal seeks to determine how translational efficiency mechanisms control C. albicans morphology and virulence. Ultimately, this study will provide new information leading to the development of novel and more effective strategies to treat candidiasis.